Probing transcriptional activation at the molecular level

Project Summary
Much of the assembly process of the transcription machinery is governed by transient and dynamic protein-
protein interactions (PPIs) that defy standard characterization strategies. Transcriptional coactivators are the
hubs of this process, interacting with transcriptional activators, epigenetic modulators, the polymerase, and other
coactivators to assemble the transcriptional machine. Coactivators also represent a central molecular recognition
conundrum, as the mechanisms by which they interact with such a diverse array with binding partners and the
influence of local binding interactions on longer-range structural and functional trajectories. In the previous
funding period, we developed a molecular recognition model that addresses the first part of the conundrum. Here
will build on this model to discover allosteric modulators of coactivators previously labelled undruggable despite
their central functional roles. Additionally, we will answer the latter half of the conundrum to develop a
comprehensive model of molecular recognition in transcriptional coactivator function.

Public health relevance
Project narrative Transcription is dysregulated in every human disease as either a cause or an effect and as such represents a potentially powerful intervention point for therapeutics; a significant impediment to progress are the many questions regarding the complex network of protein-protein interactions that regulates this process. In this research plan we implement a combination of chemical biology tools and approaches to define key binding interactions and conformational changes that produce function in vitro and in cells. In doing so, we will discover new opportunities for drug discovery, with a particular focus on transcriptional pathways integral to metabolic disease and cancer.